A next generation cross-serotype binding antitoxin for treatment of post-exposure botulinum poisoning

PROJECT SUMMARY
Botulinum poisoning is a rare neurotoxin-mediated syndrome that results in progressive respiratory and muscular
paralysis and leads to death if untreated. Aerosolized botulinum neurotoxins (BoNT) are particularly lethal and
of major concern as potential biological weapons. Given this concern, the U.S. has stockpiled the only approved
antidote for BoNT poisoning, BAT®, to be used in case of intentional or unintentional release of infectious BoNT.
BAT® consists of a polyclonal mixture of antibodies against botulinum toxin types A-G that is derived from equine
serum following a complicated and time-consuming manufacturing process. While effective in abstracting BoNT
in circulation, BAT® is associated with a number of primary safety concerns that limit its use to patients with a
confirmed botulism diagnosis. As the earliest symptoms of botulism poisoning are non-specific, BAT® treatment
is often administered well into the disease course when many patients require additional aggressive supportive
care measures such as mechanical ventilation for survival. As such, a next generation BoNT antitoxin that is
human-compatible, confers protection against multiple serotypes, demonstrates rapid clearance of circulating
toxin, and can be safely administered as an early intervention upon suspicion of BoNT exposure is critically
needed to replace BAT®. To address this need, NightHawk Biosciences, Inc. (NHB) is developing a multivalent
botulinum antitoxin product based on their novel Terminator technology, which sequesters target pathogens by
binding them to circulating red blood cells (RBCs) via receptor type I (CR1) and delivers them to fixed-tissue
macrophages for engulfment. To date, experimental results indicate that the Terminator system can be used to
induce RBC immune adherence to effectively remove a variety of pathogens from circulation, drastically reducing
the blood concentration of pathogenic particles within minutes of treatment. Critically, Terminator has
demonstrated good safety and tolerability in humans, positioning it potentially as a drug of low regret that can be
safely administered prior to clinical confirmation of diagnosis. In this Phase I SBIR, NHB will advance a
Terminator BoNT antitoxin candidate consisting of a unique antibody complex in which a human CR1 antibody
is fused to an antibody targeting the BoNT serotypes associated with human disease (A, B, E, and F). To
adequately de-risk this candidate for IND-enabling studies, this proposal will 1) demonstrate selective and high-
affinity cross-serotype binding and specific uptake into macrophages; 2) define the kinetics of Terminator-
mediated clearance of BoNTs in vivo; and 3) demonstrate efficacy to protect against BoNT poisoning in a
postexposure mouse model. Phase II studies will expand efficacy evaluations into aerosol challenge models and
initiate IND-enabling toxicology and dose-refining studies.

Public health relevance
PROJECT NARRATIVE Botulinum poisoning is a rare but lethal syndrome that results from neurotoxin-mediated respiratory and muscular paralysis. The only approved antidote suffers from high cost of goods and significant safety liabilities. NightHawk Biosciences, Inc. is developing a novel botulism antitoxin that rapidly binds and sequesters toxins in the bloodstream before delivering them directly to the liver or spleen for destruction. This next generation antitoxin candidate exhibits potential for rapid pathogen clearance and substantial improvements in manufacturing costs and safety over the currently fielded countermeasure.